NextGenSIT: An Off-the-Shelf and On-Demand Product for Biological Control of Aedes aegypti Mosquitoes

The overarching objective of this project is to finalize the development and commercialization of Synvect’s
innovative NextGenSIT technology for Aedes aegypti mosquito control. This transformative genetic
engineering solution combines precision-guided CRISPR gene knockouts with scalable deployment methods
to address the urgent global need for eco-friendly, effective, and cost efficient mosquito control. By targeting
mosquito populations responsible for spreading diseases such as dengue, yellow fever, and Zika, this project
aims to establish a new standard for combating vector-borne diseases while advancing regulatory readiness
and market viability.
Aim 1 focuses on finalizing the genetic components for the Ae. aegypti NextGenSIT eggs, leveraging
CRISPR-mediated knockouts of specific genes to ensure the production of competitive, sterile males at scale.
This work involves rigorous testing and optimization to select the most effective genetic reagents for
deployment. Aim 2 emphasizes developing and validating deployment strategies for NextGenSIT eggs. This
includes optimizing the egg-to-male transformation in the environment by deploying the produced eggs and
reusable egg-to-adult boxes to create a user-friendly and cost-effective product for large-scale application.
Aim 3 transitions from laboratory validation to semi-field and small-scale open-air pilots in Florida and Texas,
assessing deployment parameters and achieving a 90% reduction in mosquito populations under controlled yet
realistic conditions. These interim trials will bridge the gap between lab results and real-world deployment,
providing critical data on scalability, environmental adaptability, and operational efficacy. Aim 4 expands on this
foundation by conducting larger open-air pilots with government and commercial partners, validating the
real-world impact of NextGenSIT and securing the Environmental Protection Agency (EPA) approval. This
phase is critical for demonstrating product value, aligning with customer needs, and converting at least 50% of
pilot participants into long-term customers.
The expected outcomes of this project include the development of a scalable, eco-friendly mosquito control
solution with proven efficacy in reducing vector populations, securing EPA approval, and establishing Synvect
as a trusted leader in vector control technologies. By bridging lab innovation with real-world application, this
initiative will create a robust pathway for commercialization and set a new benchmark in combating
vector-borne diseases globally.

Public health relevance
The project aims to complete the development, delivery, and deployment of Synvect’s NextGenSIT product, providing an eco-friendly and cost-effective solution for Aedes aegypti mosquito control. By conducting semi-field trials and small-scale open-air pilots, the project seeks to validate efficacy while actively engaging partners and converting them into paying customers, thereby strengthening its go-to-market strategy ahead of large-scale open-air pilots under an Experimental Use Permit. These efforts will lay the foundation for full commercialization following U.S. regulatory approval.